Molecular recognition by ADAR1 of Z-RNA within transcriptomes

1 Project Summary
2 RNA editing of cellular RNAs helps the cell distinguish between self and non-self RNAs. This
3 editing of adenosines into inosines is generally catalyzed by the ‘adenosine deaminase acting on
4 RNA-1’ protein (ADAR1). A>I editing is augmented in tumors and upon infection, primarily
5 through the interferon-induced longer isoform of ADAR1 that comprises a Z-DNA/Z-RNA binding
6 domain named ‘Zα’ at its N-terminus. Misediting is implicated in neurological diseases such as
7 Aicardi-Goutières syndrome. Z-RNA in the form of repeats of cytosine and guanosine (CpG) in a
8 left-handed double-helical conformation has been proposed in cells, but the prevalence of such
9 structures and their exact role are unknown. In addition, many —if not most— regions proposed
10 to adopt a Z conformation do not resemble regular (CpG)n. How these local Z-RNA conformations
11 are generated within A-form helices, stabilized and regulated by Zα of ADAR1, as well as their
12 exact role in the function of these RNAs, remain unknown. Our hypothesis is that the binding
13 of Zα to Z-RNA plays an essential role during the editing process. Here, we propose to
14 answer the following questions: What is the mechanism for Z-RNA formation at CpG but also
15 non-CpG sequences? How widespread are transitions to Z-RNA across transcriptomes? Is Z-
16 RNA sampled in the free form or only adopted upon binding by Zα? What are the structural
17 features of Z-RNA recognition by Zα at non CpG sequences? We will first dynamically
18 characterize the propensity of various sequence contexts to adopt Z-RNA conformations.
19 This aim will use advanced NMR methods to characterize the sequence of events that lead an
20 RNA region from A-form to Z-form. Second, we will determine the unbiased 3D structure of
21 RNA fragments bound to Zα in solution. Finally, we will identify and localize Zα binding
22 sites and Zα-dependent A>I editing events. This aim will take advantage of the robust
23 expertise and support for next-generation sequencing on our campus and at a contracted
24 company. Overall, our joint work as co-PIs will provide a structural rationale for the formation of
25 Z-RNA and the resulting formation of A-Z junctions across a variety of RNAs. We ultimately aim
26 to explain how the Z-RNA binding domain of ADAR1 increases the specificity and activity of
27 ADAR1. Our findings will help beyond this application with proposing a comprehensive
28 mechanism for ADAR1 editing and its RNA-mediated transcriptome-wide regulation, and
29 contribute to understanding disease such as cancer or auto-immune deficiencies.

Public health relevance
Project narrative RNA editing of transposable elements within cellular RNAs by the ADAR1 enzyme helps the cell distinguish between self and non-self RNAs. The Z-RNA binding domain of ADAR1 plays a role in that process, which remains uncharacterized. Our goal is to structurally, dynamically and geographically (across transcriptomes) characterize the formation of Z-RNA and their recognition by ADAR1, with repercussions on better understanding cancer and certain auto- immune diseases.